DNA Methyltransferase Gene Expression in Colon Cancer

This long standing RO1 explores epigenetic abnormalities underlying the initiation and progression of colorectal
cancer (CRC), the third most common cause of cancer deaths in the US (U.S. Cancer Statistics Working Group).
We are now defining novel perspectives for CRC evolution concerning the presence and position of epigenetic
changes, key causes for how they arise and are maintained, and a new understanding of the functional
significance of the transcriptional abnormalities for the genes affected. During the last funding cycle, we have
integrally linked all of the above with environmental stresses underlying the earliest steps in CRC tumorigenesis.
These tie resulting epigenetic abnormalities to the highest CRC risk states, chronic inflammation and especially
aging. The above epigenetic dynamics intersect with, and may be obligatory for key genetic alterations to drive
the evolution of CRC. An integrating molecular paradigm for all of the above concerns our defining, during the
present funding cycle, a novel potential role for recruiting components of the NURD transcriptional repression
complex to chromatin as triggered by reactive oxygen species (ROS) exposure and resultant DNA damage .
Experimentally, this can associate with initiation and maintenance of abnormal gene expression associated with
enhancer and gene promoter DNA methylation. In this proposal, we make novel use of colon organoids to model
how the above DNA damage dynamics can underlie epigenetic abnormalities, which allow addiction to key
genetic driver mutations to foster colon CRC risk including that associated with aging. Finally, we utilize the
molecular events in the above risk paradigm for defining novel targets for reversing abnormal epigenetic gene
silencing during CRC initiation and progression. Our proposed studies are then important for derivation of new
strategies for prevention, interception, and therapy for CRC.
All of the work in our proposal has the potential to define strategies for CRC prevention, interception and therapy
underpinned by a novel relationship of the emerging data to the age-risk for these cancers.

Public health relevance
We will investigate, in colorectal cancer (CRC) cells, assembly for key components of the NURD transcription complex which we have found can trigger, during reactive oxygen species induced DNA damage in CRC, initiation and maintenance of functional epigenetic abnormalities. We have tied the downstream repressed genes involved to the age-related risk of CRC in humans and have a model for this in organoids from colon. We will explore, including in our above model and with respect to key new proteins including PARP, UHRF1 and TET2, the hierarchy of complex assembly with a translational goal of targeting key members for new strategies to prevent, intersect, and manage CRC.